CEIRR Data Processing and Communications Center Activities for Universal Influenza Vaccine Research

To provide processing for data collected and generated by the NIAID CEIRR program related to universal influenza vaccine research.